Glycoantigen evolution targeting antibodies of the PGT 128 lineage

Project Summary/Abstract
Extensive study of HIV+ individuals in recent years has brought to light many examples of antibodies that
can neutralize a broad range of HIV strains and protect against viral challenge in animal models of
infection. The portion of viral surface most commonly targeted by such antibodies is now known to be
the “high-mannose patch”: among patients producing broadly-neutralizing antibodies, 38% target this
one region of the virus. One of the most potent high mannose patch antibodies, PGT128, binds to a
particular arrangement of high-mannose glycans and conserved peptide residues. Our goal is to develop
vaccine immunogens which mimic this arrangement precisely and be used to elicit PGT128-like
antibodies.
Our approach will utilize unique directed evolution methods to develop glycoimmunogens in which
PGT128 epitope elements are correctly reconstituted. It is also possible that additional immunogens will
be required to correctly prime the immune response by stimulating germline precursors of PGT128.
Therefore, we will develop glycopeptides targeting both mature and germline PGT128 antibodies. In
collaboration with David Nemazee at Scripps, we will investigate the ability of these glycopeptides in
combination, to activate a germline PGT128 response that can mature into a response with broadly-
neutralizing PGT128-like specificity.

Public health relevance
Project Narrative The goal of this project is to develop a vaccine against HIV, which is a major goal in human health.